Enhancing the effect of fluoride for root caries control in high-risk older adults (Resub)

PROJECT SUMMARY/ABSTRACT
The problem: With an aging population, challenges to maintain good oral health are set to increase worldwide.
Systemic complications (high blood pressure, diabetes, neurodegenerative disorders) add to local factors, such
as the exposure of the more susceptible root surfaces and the use of medications that cause hyposalivation.
Collectively, these factors increase caries rates, especially root caries, and reduce the oral health and quality
of life of older adults. As oral and general health are indivisible, poor oral health outcomes in older individuals
are associated with increased frailty and mortality. Challenges to overcome the increased rate of root caries in
older adults include the lack of a specific approach for root caries control, the standard of care being the
prescription of high fluoride toothpastes. These toothpastes have modest clinical effectiveness, since the
retention of fluoride in the biofilm is not proportionally enhanced as the fluoride concentration in the product
increases. Although fluoride has been the most effective agent for caries prevention for several decades,
surprisingly, no innovations to improve its anticaries efficacy have been made. Hypothesis: We devised a new
therapy able to enhance the anticaries effect of fluoride, while maintaining its dose and safety profile. In pilot
studies, we observed that this therapy, involving the use of fluoride nanoparticles, increase by approximately
100-fold the penetration and retention of fluoride in cariogenic biofilms, and exhibit an improved fluoride-
releasing profile. Thus, we hypothesize that the positively charged nanoparticles will penetrate the cariogenic
biofilm, bind to negatively charged biofilm components, and release fluoride at levels high enough to improve
the physicochemical effect of fluoride (needed for the control of root caries) as well as inhibit acid production by
the biofilm (reducing the predominance of acid-producing species, i.e. biofilm dysbiosis). This hypothesis will
be tested in the following specific aims: S.A.#1: Define the mechanisms of interaction between the therapy
components and dental biofilm; S.A.#2: Determine the effects of the therapy on root dentin demineralization;
S.A.#3: Establish the efficacy and safety of the therapy for caries control using in vivo rodent caries models.
Significance: Upon successful completion of this project, we will understand the preventive potential of a new
anticaries approach to reduce the cariogenicity of dental biofilm and control root caries. This work has the
potential to exert a long-lasting impact on the control of rampant caries progression in high caries-risk groups
and improve the health and quality of life of older adults suffering from hyposalivation.

Public health relevance
PROJECT NARRATIVE Older adults who take medications that cause dry mouth suffer from aggressive caries progression, especially in the roots of teeth. An innovative treatment has been developed to boost the effect of fluoride by the use of fluoride-releasing nanoparticles engineered to penetrate and bind to the cariogenic dental plaque. The high fluoride level induced in dental plaque by this treatment, without increasing the level of exposure to the ion, can reduce root caries progression in individuals with dry mouth.